Mycobacterium tuberculosis disease effect on HIV-1 immunity, evolution, and persistence

PROJECT SUMMARY
Worldwide, Mycobacterium tuberculosis (Mtb) is the most common co-infection in people living with HIV
(PWH). Although, studies have conclusively demonstrated that HIV-1 enhances the development and
progression of Mtb disease, there is limited understanding into Mtb disease effects on HIV-1 pathogenesis. We
have observed that PWH with pulmonary Mtb disease (PWH/Active Mtb) as compared to PWH/No Mtb have
broader and more potent HIV-1 neutralizing antibodies (nAbs). We have also shown that PWH/Active Mtb as
compared to PWH/No Mtb have lower levels of intracellular HIV-1 RNA, suggesting they have lower HIV-1
transcription in the latently infected cells. We hypothesize that Mtb disease changes both the HIV-1 immune
response and the characteristics of the viruses present in PWH. This is important because our knowledge
about HIV-1 pathogenesis primarily comes from individuals that do not have concomitant Mtb disease; the
ubiquitous HIV-1 Mtb syndemic provides an imperative to understand the effects of Mtb in PWH. Mtb disease
likely influences multiple aspects of HIV-1 pathogenesis. Broad and more potent HIV-1 nAbs select for
resistant strains, and we will assess if Mtb disease leads to the emergence of more nAb resistant strains. We
will also use ex-vivo and tonsil organoid models to examine if Mtb disease enhances nAbs by increasing the
frequency and functionality of T follicular helper cells, which are an essential component of a broadly potent
humoral response. Antibodies can also mediate effector cell function through Fc domains, such as antibody
dependent cellular cytotoxicity (ADCC). We will also examine if Mtb disease selects for ADCC resistant strains.
Resistant viruses are a primary reason it has been difficult to prevent HIV-1 transmission through vaccination
and induce virus remission. Achieving virus control without antiretroviral therapy will likely require the
eradication of latently infected cells that have the ability to transcribe HIV-1 or remodeling that prevents HIV-1
transcription. The inflammation that accompanies Mtb disease largely accounts for the associated morbidity
and mortality. We hypothesize that the Mtb immune dysfunction or the altered HIV immune response directly
affects the characteristics of residual infectious latent HIV-1 reservoir. We will test whether Mtb disease
associated inflammatory dysregulation either potentially enhances virus production which leads to elimination
of infected cells through immune clearance, such as ADCC, or viral cytopathic effect, or it potentially induces a
deeply latent state in infected cells. Mtb disease mediated influence on HIV-1 immunity and the subsequent
effect on frequency of resistant strains has direct implications for future vaccine strategies that aim to elicit
broadly potent nAbs. The frequency of antibody resistant strains also affects the use of broadly neutralizing
antibodies for prevention and treatment. Furthermore, Mtb disease mediated changes to the HIV-1 latent
reservoir will highlight the types of inflammatory and immune interventions that will be required to decrease the
transcriptional capacity of the HIV-1 latent reservoir, in-vivo.

Public health relevance
PROJECT NARRATIVE Although Mycobacterium tuberculosis (Mtb) is the most common co-infection among people with HIV (PWH) worldwide, there is limited understanding about how Mtb affects HIV-1 immuno-pathogenesis. We have observed that PWH with active Mtb disease as compared to PWH and no Mtb disease have both broad and potent anti-HIV-1 neutralizing antibodies and latent cells with lower levels of HIV-1 cell-associated RNA expression. We hypothesize that Mtb disease affects HIV-1 immune responses and the characteristics of the virus present in PWH, and this has direct implications for future strategies aimed at decreasing HIV-1 transmission and inducing virus remission.